Proteomics Core

OK-INBRE PROTEOMICS CORE SUMMARY
The goal of the OK-INBRE Proteomics Core is to provide researchers in Oklahoma access to
state-of-the-art instrumentation and expertise for advanced mass spectrometry. The core is
organized with the instrumentation and expertise required to make discovery proteomics and
targeted quantitative proteomics experiments available to researchers in Oklahoma. The
discovery proteomics experiments (Aim 1) will use data-dependent and data independent
acquisition (DDA and DIA, respectively) to identify and quantify with label free methods the
abundance of several thousand proteins in complex samples. The targeted quantitative
proteomics experiments (Aim 2) will use selected reaction monitoring (SRM), parallel reaction
monitoring (PRM), and DIA to selectively detect and quantify proteins based on peptides formed
by trypsin digestion. To ensure state-wide awareness of the core’s capabilities and access to
these methods, Aim 3 will, a) continue a series of workshops to describe our methods and
educate potential users and b) provide vouchers to defray any charges associated with pilot
projects.